Arkansas ECHO ISPCTN Site (AREIS)

PROJECT SUMMARY
Children living in rural regions of the United States have limited opportunities for research participation. The
Institutional Development Award (IDeA) Program was launched in 1993 to enhance biomedical research
opportunities in states with low rates of National Institutes of Health funding. The Environmental influences on
Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials Network (ISPCTN) was formed in 2015 to
provide clinical trial participation opportunities to children living in IDeA states and to enhance workforce capacity
for pediatric clinical trials. The ARkansas ECHO ISPCTN Site (AREIS) based at Arkansas Children’s Research
Institute will build upon previous work and continue to expand research participation opportunities for children
living in rural regions in Arkansas. To this end, AREIS will continue to work closely with the Data Coordinating
and Operations Center, with other ISPCTN sites, and with local experts affiliated with the Clinical and
Translational Sciences Award at the University of Arkansas for Medical Sciences. In the next cycle of funding,
AREIS will 1) provide research expertise and leadership to the ECHO ISPCTN for the development and
implementation of robust clinical trials in high priority ECHO focus areas; 2) increase clinical trials competency
and leadership skills among AREIS faculty and staff; and 3) leverage existing resources to implement innovative
community engagement and community partnership approaches that will enhance the participation of rural
children in clinical trials. Innovations in clinical trials, such as the incorporation of telehealth approaches, will
allow AREIS to conduct research in low-resourced settings, such as rural communities. The collective impact of
this research with increase the enrollment of rural children in clinical trials in ECHO focus areas and increase
clinical trial competencies among faculty and staff affiliated with AREIS. In addition, the continued development
of strong partnerships with other ISPCTN sites and the DCOC will enhance the success of future research
collaborations in ECHO priority areas.

Public health relevance
PROJECT NARRATIVE Children living in rural regions of the United States (US) have reduced access to medical care and few chances to participate in research. This project will address this problem by working in collaboration with a group of pediatric researchers to develop and conduct research studies that improve general knowledge of diseases common in children in rural areas, such as asthma, opioid addiction, and obesity. By enhancing the research skills of junior researchers and supporting research interactions with communities, this project will increase research participation and enhance the health of children living in rural regions of the US.